Adaptation and feasibility testing of an AI-enabled web app based on acceptance and committment therapy for family caregivers of people with dementia

Project Summary/ Abstract
The greatest unmet need in family caregivers of persons living with dementia (PLWD) is support for
these caregivers’ mental health. Family caregivers of PLWD express a desire for mental health support
and a need to learn strategies to cope better with the emotions and thoughts that arise from caregiving
situations and to balance care demands with other important aspects of life. Acceptance and
commitment therapy (ACT) is an evidence-based transdiagnostic approach that can promote mental
health through acceptance and mindfulness processes and behavior change processes that support
living in alignment with values. Previous studies focused on in-person ACT programs, but internet-
delivered self-help ACT programs have the potential to increase caregivers’ access to mental health
support at low cost. The current study's objectives are to adapt and finalize our artificial intelligence (AI)-
enabled ACT app for family caregivers of PLWD and to test its feasibility, acceptability, and usability. The
proposed study will have two phases. The first phase aims to adapt our AI-enabled ACT web app
(WeACT) through collaboration with a community advisory board (Aim 1). The second phase aims to
evaluate the feasibility, acceptability, and usability of the WeACT app program for family caregivers of
PLWD as a small feasibility (Aim 2). This feasibility study will involve a convergent mixed-methods study
design (i.e., a one-group pretest–posttest design with a phenomenological approach). Twenty family
caregivers of PLWD will be recruited and asked to use the WeACT app in the manner determined in Aim
1. Feasibility and usage of the app will be assessed with the number of days and total minutes of
engagement with the app during the study period. Adherence to the app-based program will be
determined through the completion rates of ACT modules, evaluations, and ACT practice on the app in
the manner determined in Aim 1. Caregivers’ acceptability, perceived usability, and experiences in the
program will be explored using an individual interview and a usability scale. Preliminary data on
caregivers’ mental health outcomes and ACT processes will be collected using self-reported
questionnaires. We will refine and finalize the app based on the feedback from caregivers (Exploratory
Aim). This study will provide important guidance for further development of the WeACT app for future
larger-scale clinical trials to promote mental health in family caregivers of PLWD. Given the evidence that
the greatest unmet need among family caregivers of PLWD is support for mental health, the findings will
contribute to the timely development of an evidence-based, easily accessible mental health app.

Public health relevance
Project Narrative The proposed research is relevant to public health because the study aims to adapt and finalize our web app based on acceptance and commitment therapy for family caregivers of people with dementia and to test its feasibility, acceptability, and usability. The greatest unmet need in these caregivers is support for mental health, and the findings will contribute to the timely development of an evidence- based, easily accessible mental health app. Thus, the proposed research is relevant to the National Institutes of Health’s mission of enhancing human health.